INFORMATION TECHNOLOGY 2009

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The IT Department provides local and wide area network connectivity, file and print services, database administration, information security support, Internet and Intranet web site development and maintenance, application development, training and end-user assistance to approximately 200 Center staff. AIDS related.